Disentangling the effects of daily stress, sleep, and sex hormones on accelerated vascular aging in midlife women

PROJECT SUMMARY
Cardiovascular disease (CVD) morbidity has increased by up to 30% in midlife women in the last 20 years. Increased
CVD risk in midlife women is at least partially explained by declines in estradiol (E2) that occur across the menopausal
transition and accelerate vascular aging. Although vascular dysfunction has been noted in early perimenopausal
women, our novel preliminary data show that reductions in endothelium-dependent dilation are evident in some
premenopausal midlife women, strongly suggesting that the development of endothelial dysfunction in midlife
precedes the menopausal transition and thus cannot be solely explained by the loss of E2. Emerging factors that may
help explain accelerated vascular aging in midlife women include greater emotional responsivity to daily stressors and
greater sleep irregularity. While both common features of menopause, these dynamic constructs can vary across the
menopausal transition and are independently related to disruptions in vascular homeostasis. As such, amplified
emotional responsivity to daily stressors and greater sleep variability may represent novel, modifiable, biobehavioral
mechanisms to help explain the inter-individual variability in the degree of vascular endothelial dysfunction in
premenopausal midlife women. The objective of this proposal is to test the central hypothesis that (a) greater negative
affective responsivity to daily stressors and (b) greater sleep variability will each be related to more severe declines in
endothelial function in premenopausal midlife women and that these associations will be magnified during E2
suppression (simulated menopause) compared to during natural cycling. To test this, 30 pre- menopausal middle-aged
women (45-55 years) will complete two ‘measurement bursts’ (randomized, crossover): one while naturally cycling and
one during simulated menopause using an ovarian hormone suppression intervention [daily subcutaneous injections of
a gonadotropin-releasing hormone antagonist (GnRHant; Ganirelix acetate)]. On days 1-10 of each burst, we will
assess multiple dynamic aspects of daily stress processes (mobile app-based daily diary approach) and sleep health
(wrist accelerometry). On days 0 and 11 (i.e., pre and post), we will use orthogonal laboratory-based techniques to
examine the mechanistic regulation of microvascular endothelial function (intradermal microdialysis coupled with laser
Doppler flowmetry), an approach that allows for a detailed characterization of vascular endothelial function. This
multipronged, multidimensional framework will allow for a comprehensive examination of behavioral and
physiological factors in the context of aging and changes in reproductive hormones to better understand subclinical
CVD risk in midlife women—a priority of the Trans-NIH Strategic Plan for Women’s Health Research. The
anticipated outcomes will provide proof of concept that emotional responsivity to daily stressors and sleep health are
potentially potent, modifiable mechanisms contributing to inter-individual heterogeneity in vascular dysfunction in
midlife women. As such, this line of inquiry is uniquely poised to inform subsequent, larger and fully powered trials to
test the effects of behavioral (i.e., stress reduction, improved sleep) and/or pharmacological (i.e., hormone intervention)
strategies to preserve vascular health during menopause, thereby mitigating CVD risk.

Public health relevance
PROJECT NARRATIVE Cardiovascular disease (CVD) risk in women increases dramatically at midlife but cannot be fully explained by declining estradiol (E2) during the menopausal transition. Amplified emotional responsivity to daily stressors and greater sleep variability are common in midlife women and are emerging biobehavioral factors independently associated with vascular endothelial dysfunction, a key contributor to increased CVD risk. We will use a gold-standard randomized, crossover, clinical trial design in midlife premenopausal women to determine whether simulated menopause magnifies the associations between greater vulnerability to daily stress and sleep variability with poorer vascular function.